Image-based Systems Biology of Vascular Co-option in Brain Tumors

ABSTRACT:
Recent clinical and preclinical evidence has shown that gliomas can initially grow, invade, evade antiangiogenic therapies
and eventually recur by hijacking or “co-opting” the brain’s preexisting blood vessels. Vascular co-option is a
nonangiogenic glioma growth mechanism in which, co-opting tumor cells cause astrocytes to lose intimate contact with
blood vessels, i.e. cause gliovascular uncoupling (GVU), and alter cerebral hemodynamics. Additionally, in aggressive high-
grade gliomas (e.g. glioblastoma or GBM), vessel co-option facilitates the migration and invasion of cancer cells into
healthy brain tissue. Yet, the evolution of vessel co-option over the glioma’s life-time, resultant GVU and hemodynamic
changes remain poorly understood due to a lack of microvascular-resolution lifecycle and multimodality/multiscale
imaging approaches. Moreover, co-optive glioma growth is radiologically undetectable due to an absence of contrast
enhancement and the lack of specificity of conventional MRI (e.g. T2/FLAIR) approaches. Therefore, our goal is to use an
image-based systems biology approach to elucidate the hemodynamics of co-optive glioma over its lifecycle and
develop an fMRI biomarker of co-option induced GVU. Guided by compelling preliminary data, we will pursue three
Specific Aims: (1) Characterize vessel co-option in a patient-derived glioma xenograft (PDX) over its lifecycle with
multiscale imaging; (2) Develop an image-based model of brain-wide hemodynamic changes induced by vessel co-option
in glioma; and (3) Determine if rs-fMRI can detect vessel co-option induced GVU in a patient-derived glioma xenograft.
Under Aim1, we propose a paradigm-shifting approach that employs a miniscope for microvessel resolution (~5 µm)
multicontrast in vivo imaging of co-option induced hemodynamic changes over the lifecycle of a patient-derived glioma
xenograft. We will complement these microvascular-scale measurements with multimodality/multiscale whole-brain data
from ex vivo CT/MRI/light sheet microscopy (LSM) in the same animal to corelate structural/functional/cellular changes
in the vascular microenvironment (VME). Under Aim2, we employ these data in a model of co-option induced
hemodynamic dysregulation to simulate brain-wide changes that could be exploited as fMRI biomarkers of co-optive
glioma. Under Aim3, we will determine if resting-state fMRI (rs-fMRI) can detect GVU in a co-optive PDX and differentiate
it from non-co-optive glioma growth. Our approach is innovative because it blends cutting-edge advances in miniaturized
microscopy, multiscale/multimodality imaging and image-based systems biology. The proposed research is significant
because these studies will establish: (i) freely downloadable, co-registered multiscale data for cancer systems biology
investigators; (ii) a hemodynamic model for co-optive glioma; (iii) a novel biomarker of glioma co-option with the potential
to transform patient management and stimulate the development of therapies to thwart antiangiogenic resistance. We
also expect this approach to be adaptable to other CNS diseases dependent on vessel co-option (e.g. brain metastases).

Public health relevance
The proposed research is relevant to public health because the development of novel imaging tools and models that reveal how cancer cells hijack (i.e. co-opt) pre-existing blood vessels in the brain will yield invaluable insight into brain cancer progression, tumor spread, and development of drug resistance. The proposed research is relevant to the NIH’s mission because the mechanism of vascular co-option in brain cancer remains poorly understood, and studying it in clinically relevant brain tumor models would help us understand how resistance to antiangiogenic therapies develops, and enable the identification of new biomarkers and treatment strategies for patients with brain cancer.